Integrating Sleep and Circadian Factors into Machine Learning Models for Personalized Glycemic Response Prediction

PROJECT SUMMARY/ABSTRACT
There is increasing consumer interest in using continuous glucose monitors (CGMs) for personalized
nutrition and health optimization. However, while CGMs can identify postprandial glucose spikes that contribute
to type 2 diabetes (T2D) and cardiovascular disease (CVD), the ability to predict abnormal postprandial
glucose responses (PPGRs) remains limited—undermining efforts to offer tailored dietary advice. A key
challenge is that even when the same meal is consumed, PPGRs can vary dramatically within individuals due
to the timing of behavioral factors like sleep, food intake, and physical activity. Despite this, existing machine
learning (ML) models do not account for circadian biology, even though evidence from our group and others
shows that eating at the “wrong” circadian time (e.g., at night) leads to significantly worse glycemic control.
Moreover, current models are trained on datasets with minimal repeated-meal trials, limiting their ability to
separate physiological signal from noise. To address this gap, we will leverage a funded R01 study in adult
night shift workers undergoing 8 weeks of tightly controlled feeding and CGM monitoring—producing
thousands of PPGR data points linked with detailed sleep, activity, and dietary timing data. Our overall
objective is to improve the accuracy and generalizability of ML-based PPGR prediction models by accounting
for real-world circadian and behavioral variability.
In Aim 1, we will quantify within-subject PPGR variability and determine the relative impact of circadian
factors using linear mixed-effects models and actigraphy-derived sleep metrics. In Aim 2, we will develop ML
models that incorporate both traditional features and novel circadian predictors, benchmark them against
existing models, and validate generalizability in five external NIH-funded datasets. Successful completion of
this project will make progress towards scalable personalized glucose response prediction tools that can inform
CGM-based dietary guidance and help reduce cardiometabolic disease risk in populations experiencing sleep
and circadian disruption.
This Re-Entry Supplement will also support the return of Dr. Corey Rynders to independent research
following a family-related career interruption, equipping him with critical skills in data science and ML-based
approaches to nutrition research.

Public health relevance
PROJECT NARRATIVE Abnormal postprandial glucose responses are a key risk factor for the development of type 2 diabetes and cardiovascular disease. Although consumer CGMs are increasingly used for health tracking, current glucose prediction models fail to account for behavioral timing, such as sleep and circadian rhythms, which strongly influence glucose metabolism. This project aims to improve the accuracy and personalization of CGM-based dietary guidance by integrating circadian and other timing-related behavioral data into machine learning models to support non-pharmacologic strategies to reduce cardiometabolic risk in free-living populations— including shift workers and individuals with disrupted sleep—who represent a growing share of the U.S. workforce.